Predicting Future Liver Remnant Function and Growth Trajectory Using Novel MR Imaging Biomarkers

PROJECT ABSTRACT
Hepatocellular carcinoma (HCC) is the fourth leading cause of cancer-related deaths in the world. In fact, HCC
is the fastest growing cause of all cancer deaths in the United States with a poor 5-year survival rate of 18%.
The only curative therapies for HCC are liver transplantation or liver resection (partial hepatectomy) and for
non-surgical candidates ablation. Malignant tumors within the liver, whether primary or secondary, are the most
common indication for curative partial hepatectomies. However, many patients with HCC have underlying
cirrhosis or some degree of liver dysfunction. As a result, the most severe complication after surgery remains
post-hepatectomy liver failure with a mortality rate between 1.2 to 33.8%.
Successful curative partial hepatectomy requires sufficient liver regeneration and function to avoid post-
operative hepatic insufficiency. Currently, potential surgical candidates are identified by determining future liver
remnant (FLR) volume. There are no clear guidelines for FLR volume in mild-moderate liver disease. It is
known that portal blood flow is a key parameter driving liver hypertrophy but is not well understood.
We hypothesize that there is a relationship between portal blood flow, FLR growth trajectory, and liver function.
To investigate, we will perform partial hepatectomies in 7 healthy pigs with 3 controls undergoing a sham
surgery. All 10 pigs will undergo magnetic resonance (MR) Imaging at 4 separate time points (pre-operative,
post-operative day [POD] 0, between POD 6-8, and between POD 26-30) to evaluate for portal blood flow
using a novel “4D flow” MR method, liver volume, and liver function. Our imaging time points will help assess
the first two aims – demonstrating the utility of quantitative MR imaging biomarkers in predicting FLR function
and growth trajectory, and also determining the relationship between FLR function and volume over time.
Finally, we aim to determine the effects of portal hyperemia via a meal challenge to assess portal system
accommodation and compliance as a predictive parameter. Our goal is to predict FLR function and growth to
improve patient selection, pre-operative surgical planning, and outcomes through a series of three aims.
The applicant, Devashish Joshi, MD, is a general surgery resident at the University of Wisconsin-Madison
pursuing a career as a surgical oncologist and independent investigator. This fellowship would support his
second year of dedicated research time with minimal clinical responsibilities. His sponsor, radiologist Dr. Scott
Reeder, and co-sponsor, hepatobiliary surgical oncologist Dr. Sharon Weber, have significant track records of
mentoring surgical trainees. They will guide and mentor Dr. Joshi in completing the proposed project to
improve care in patients with liver cancer and build his foundations towards becoming a surgeon-scientist.

Public health relevance
PROJECT NARRATIVE Post-hepatectomy liver failure is the most severe surgical complication with a mortality rate ranging from 1.2 to 33.8%. My proposed research project will use a novel Magnetic Resonance (MR) Imaging sequence to analyze portal blood flow and correlate the results with existing MR sequences for liver volume and function. By predicting future liver remnant function after partial hepatectomies through novel parameters, our project will improve patient selection, pre-operative surgical planning, and outcomes in patients with liver cancer.